ORAL COLLORAL IN PATIENTS WITH RHEUMATOID ARTHRITIS

Evaluate long term safety and tolerability of chronic daily dosing of colloral in adult patients with rheumatoid arthritis in whom concomitant medication is not restricted.